ECOG Clinical Trials

DESCRIPTION (provided by applicant): Since 1973, Northwestern University has been a funded member of the Eastern Cooperative Oncology Group (ECOG). Through the years, the University has consistently offered its resources and investigator commitment to both the scientific development of ECOG and to the accrual of patients to ECOG clinical trials and ancillary studies. Northwestern's Robert H. Lurie Comprehensive Cancer Center provides the essential structural support for the University's ECOG program including its affiliated institutions (Cooperative Group Outreach Program [CGOP]). The Cancer Center successfully maintained its NCI Core Grant funding (P30 CA060553) and is a NCI Comprehensive Cancer Center. Furthermore, the Cancer Center has continued to integrate its clinical and laboratory science programs into a well-defined structure which provides important shared resources for Cancer Center members to support ECOG activity (e.g., Clinical Research Office, Serum and Tissue Banks, hematopathology, etc.) Al B. Benson III M.D., F.A.C.P. continues his role as Principal Investigator for Northwestern's ECOG grant. Both physicians maintain leadership roles within the Cancer Center resulting in enhanced integration of ECOG and Cancer Center activity. Northwestern's commitment to ECOG is exemplified by its consistent entry of new patients to ECOG trials with a substantial number of cases in follow-up each year. In addition, Northwestern investigators continue to chair numerous ECOG clinical trials and hold a number of key leadership positions within ECOG which include: Gl Committee chair (Benson), Data Monitoring Committee chair (Benson), elected Nominating Committee member (Benson), Gl Steering Committee to Rectal and Cancer Task Force (Benson), ECOG Member NCI Hepatobiliary Task Force (Mulcahy), Leukemia Committee chair (Tallman), Oncology Nursing Committee chair (O'Brien), Lymphoma Committee co-chair (Gordon) Patient Outcomes ans Survivorship Committee Chair (Cella, Wagner), Genito-Urinary Pathology Co-Chair (Guang Yu Yang) and the Pathology Coordinating Office-Reference Laboraotory (Ximing Yang). Since 2004, Northwestern investigators have authored or co-authored 112 publications and 98 abstracts and accrued 1421 patients (451 main /970 affiliates) with 1927 patients (460 main /1467 affiliates) in follow-up.